Dimensional Adversity and Neural Vulnerabilities for Substance Use Among Rural and Non-Rural Adolescents

PROJECT SUMMARY
Youth living in resource-poor rural environments are disproportionately exposed to chronic stress such as
violence, parental separation, limited access to health services, and low-quality education. Converging research
links exposure to these stressful environments to early-onset substance use, heightened adolescent substance
use, and substance use disorders in adulthood. Moreover, emerging research suggests that chronic stress alters
development of critical neural systems that are associated with downstream substance use problems. Distinct
patterns of dysregulated activity within emotion regulation and reward processing systems have been
consistently observed in populations with substance use problems. Despite the ample evidence supporting
associations between these neural processes and substance use, studies investigating these patterns in
adolescents are few and often under-powered. Additionally, few studies investigating neural vulnerabilities for
substance use have considered the effects of dimensions of adversity (e.g., threat and deprivation), which are
differentially linked to neural development and behavioral adaptation. As such, the applicant proposes a
longitudinal study of the contributions of threatening and depriving experiences within the family and community
to development of altered neural function during reward processing and emotion regulation. To do so, the
applicant will employ 2 existing multi-wave imaging studies, including a highly powered and diverse national
sample (Adolescent Brain & Cognitive Development, or ABCD) and a local sample centered on adolescents
within rural communities (Development of Risk & Resilience Among Rural Youth, or DORRY). These samples
provide complementary multi-level and multi-modal assessment of the community, family, and adolescent
neurocognitive function across both national and targeted populations. Through this research, the applicant aims
to inform the development of earlier and more sensitive risk assessments and more targeted methods of
prevention among youth at risk for substance use.
During the course of the proposed study, the applicant will receive extensive training in advanced statistical
methods, neurocognitive foundations of addiction, analysis for neuroimaging findings, and assessment of
community risk and parenting. The applicant’s environment is ideal for the proposed study and training plan: the
sponsor of the application is a leading researcher in cognitive neuroscience and addiction, while the co-sponsor
has extensive experience researching adolescent risk and resilience, chronic stress, and family processes.
Moreover, the research is taking place within the UGA Neuroscience Program, which provides extensive support
for the applicant in the form of training, coursework, and funding, and the UGA Bio-Imaging Research Center,
which houses a state-of-the-art 3T scanner and ample space for data collection and analysis.

Public health relevance
PROJECT NARRATIVE Chronic stress conferred by dimensions of adversity (e.g. threat and deprivation) within the family and community contexts is associated with aberrant patterns of neural function and, consequently, increased risk for substance use during adolescence. Less is known, however, about the longitudinal and concurrent development of emotion regulation and reward processing neural systems in relation to dimensional adversity. The current proposal aims to determine the role of threatening and depriving experiences in development of neurocognitive function underlying substance use risk among adolescents.